Cure Sickle Cell

The Cure Sickle Cell (CureSC) Initiative was created in 2017 by the National Heart, Lung, and Blood Institute (NIH/NHLBI) to:

• Actively engage the sickle cell disease community of patients, family members, caregivers and advocates to work together on a path to the cure
• Utilize the emergence of safe reliable genetic therapies that broadens opportunities to improve the lives of individuals with sickle cell disease
• Use public-private partnership and collaboration among government agencies, biopharmaceutical companies and researchers to result in more rapid advancement of new and innovative treatments and technologies